Resolution of inflammation after cardiac arrest

Abstract
Out of hospital cardiac arrest (OHCA) produces an early systemic inflammatory response associated with
significant neurological injury and mortality. Unlike sepsis, OHCA offers an opportunity to intervene at the
earliest stages of the immune response. However, the immunology of cardiac arrest is understudied. To
address this, we started the multi-center Immunology of Cardiac Arrest Network (I-CAN), a collaboration
applying single-cell approaches to a unique biobank of cryopreserved, viable peripheral blood mononuclear
cells (PBMC) from OHCA patients. Our premise is that cardiac arrest triggers endogenous, compensatory
mechanisms that promote the resolution of inflammation, limit injury and improve survival. Our preliminary
studies identified that monocyte and NK cell states expressing immune checkpoints were expanded in patients
with poor neurological outcomes. Interactome analysis identified cytokines (IFNγ, IL-10) that mediate cross-talk
between Nectin-2+ monocytes and Tim-3+ TIGIT+ NK cells. Subsequent ex vivo studies on PBMC from OHCA
patients demonstrated that Nectin-2 is a brake on production of IFNγ by NK cells. IFNγ-deficient mice in
experimental cardiac arrest and resuscitation had reduced neurological injury and mortality. These findings
suggest our hypothesis that Nectin-2 monocytes are a protective response to ameliorate inflammation and
neurological injury after OHCA. Here, we propose to define the mechanisms that resolve inflammation after
cardiac arrest. In Aim 1, we perform deep immunophenotyping of OHCA patients at single-cell resolution. In
Aim 2, we define the immune checkpoint profile of OHCA and its association with neurological outcomes. We
then define the function of immune checkpoints in OHCA, with a focus on Nectin-2+ monocytes. In Aim 3, we
test targeting of immune checkpoint receptors as a therapeutic strategy in a mouse model of cardiac arrest and
resuscitation. Together, these aims define a new therapeutic approach: augmentation of endogenous,
protective mechanisms to reduce inflammation after cardiac arrest. Further, our multi-center and multi-
disciplinary team in the Immunology of Cardiac Arrest Network (I-CAN) establishes the resource of a two-site
biorepository of clinical cardiac arrest with deep immunophenotyping of the subjects.

Public health relevance
Project Narrative After someone’s heart stops beating (“cardiac arrest”), chest compressions (“CPR”) can restart their heart. However, many patients later die from brain damage, and we lack medications to prevent this brain damage. We are targeting the immune system to help protect the brain after cardiac arrest. 2